SCOR--OCCUPATIONAL AND IMMUNOLOGICAL LUNG DISEASES

This application requests support to continue a highly successful SCOR in Occupational and Immunologic Lung Disease at the University of Iowa. The overall goal of the Occupational and Immunologic Lung Disease SCOR Program at Iowa is to perform coordinated interdisciplinary research aimed at elucidating the basic mechanisms for the development of disease in these disorders. A related goal of the SCOR Program is to determine if information obtained from these basic studies improves the care of patients with Occupational and Immunologic Lung Disease. The basic and clinical studies that were chosen for the renewal of this program are highly interactive and the success of each of the projects will be significantly enhanced by the interactions within the SCOR Program. There are six projects and four cores in the program. Project I (Determinants of the Disease Activity and Prognosis for Interstitial Lung Disease) is the clinical project which will determine factors which predict prognosis in patients with sarcoidosis, asbestosis, idiopathic pulmonary fibrosis, and interstitial lung disease associated with Rheumatoid arthritis. Projects VI-X (VI: Regulation of PGH Synthase in alveolar Macrophages from Normal Individuals and Cigarette Smokers; VII: Inflammatory Effects of PMN Metabolites of Linoleic Acid; VIII: Interaction of Latent Viral Genes with Cell-Derived Cytokine Genes; IX: Human Cytomegalovirus Immediate Early Gene Expression in Inflammatory Cells of the Human Lung and Their Effects on Promoters; and X: Post-transcriptional Regulation, Processing and Secretion of Interleukin-I) are basic studies which evaluate various aspects of the pathophysiology of these disorders. Acquisition of new information from these studies should enhance our disorders. The six projects in the Occupational and Immunologic Lung Disease SCOR will be supported by four core facilities: Administration, Biometry, Clinical, and Pathology. The research team consists of investigators from the University of Iowa College of Medicine and the University of British Columbia (Vancouver, B.C., Canada), Departments of Medicine, Microbiology, Biochemistry, Pediatrics, Radiology, Physiology, Pathology, and Preventive Medicine/Biostatistics. Essentially all of these investigators have interacted closely in research projects for some time.